Cancer Research Training & Education Core

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION – SUMMARY/ABSTRACT
The goal of the Cancer Research Training and Education Coordination Core (CRTEC) is to provide, integrate,
and coordinate education, training, and career development activities across all Research Programs within the
UVACC community. It does so in the setting of a highly collaborative cross-campus education and professional
development portfolio offered through the UVA Schools of Medicine, Engineering and Applied Science, Arts &
Science, Data Sciences, and Education. With this strong infrastructure in hand, the CRTEC Core partners with
the CCSG Research Programs and Shared Resources to provide trainees with a program of study built on a
platform of impactful cancer research, an innovative cancer-focused curriculum, and robust career
development programs. The CRTEC also works with departments, divisions, and UVACC Members to offer
strong mentoring and career development for junior faculty in the UVACC. Finally, it coordinates cancer-
focused educational and experiential initiatives for grade and high school students, and partners with the
Research Programs and Community Outreach and Engagement (COE) Core to provide continued education
for health care professionals on-site and within the catchment area. In each of these endeavors, the CRTEC
Core places value on engaging a diverse community of learners that will enhance the research and
educational enterprise of the UVACC. Our education and training programs have met with great success
during the previous grant cycle, with strong publication records, numerous awards and fellowships, competitive
postdoctoral and faculty positions for our trainees; advancement for our junior faculty; and training for our
health care professionals. These accomplishments will be augmented by several new initiatives planned for
the next grant cycle, which include (1) expanding our footprint in K-12 education; (2) partnering with COE to
use telemedicine and the Project ECHO platform to help educate health care providers in our catchment area;
and (3) formalizing a summer research program for faculty from minority-serving institutions that will open
doors to new multi-institutional collaborations and encourage their students to pursue careers in cancer
research.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.